NIDCD National Temporal Bone Hearing and Balance Pathology Resource Registry

Project Summary
A comprehensive program is proposed to facilitate 1) recruitment of human temporal bone
donors, 2) accrual and distribution of donated specimens to active laboratories, 3) development
and maintenance of searchable de-identified databases including diagnoses, histopathological
summaries, audiometric data and complete sets of digitized images, 4) brokering of special
needs of research investigators using human otologic material, and 5) educational efforts
including educational outreach to the public and interested professionals including scientists and
organ procurement specialists and undertakers. As has been the case for the last 26 years, this
will be accomplished through the maintenance and enhancement of a coordinated Temporal
Bone Registry Office. The proposed Registry function will be overseen by Felipe Santos, M.D.
(Principal Investigator) with assistance from Alicia Quesnel, M.D. (Co-Prinicpal Investigator) and
M. Charles Liberman, Ph.D. (Co- Principal Investigator). Additional input will be solicited from
other Departmental members with experience and professional interest in furtherance of human
temporal bone histopathology, including D. Bradley Welling, M.D., Ph.D and Joseph B. Nadol,
M.D.
Additional oversight will be provided by the NIDCD Program Coordinator for the Registry who
will help in the selection of a Steering Committee including the PI of the Registry, the Project
Coordinator and 2 to 3 external scientists with an understanding and appreciation of the value of
otopathology and basic otologic research.

Public health relevance
Narrative Pathologic study of disease processes and evaluation of treatment modalities are critical aspects of the scientific basis of medicine. Many disorders of hearing, balance and facial nerve function are incompletely understood in part due to deficient pathologic information. The ongoing mission of the National Temporal Bone Hearing and Balance Pathology Resource Registry is to facilitate information sharing, solicitation of human temporal bone donors during life, the procurement of specimens as soon as possible after death and coordination of the study of these specimens either by 1) histological methods such as conventional microscopy or more modern techniques such as multi-label immunofluorescence confocal microscopy, 2) gene expression approaches such as molecular genetic and proteomic methodologies, or 3) imaging approaches such as advanced microstructural MRI or synchrotron radiation imaging.